Neurodevelopment of Emotional Interference Resistance in Adolescence to Adulthood: A Multimodal Neuroimaging Approach

Project Summary
Childhood trajectories of high or increasing internalizing and externalizing symptoms appear to mutually re-
enforce one each other and be associated with the emergence and exacerbation of pathology in early adolescence
and early adulthood. They have been linked with alterations in neural networks underlying emotional
interference resistance—the ability to sustain attention on goal-relevant information while resisting interference
from irrelevant emotional stimuli. Although, these neural networks undergo maturational changes during
adolescence, their development in relation to improvements in emotional interference resistance has yet to be
well characterized. Examining neural activity to emotional distracters during working memory provides rich
information about the temporal sequence of emotional interference resistance. Emotional distracters recruit an
extended affective visual system (AVS) comprised of the occipital-temporal cortex, medial temporal
lobe/amygdala, ventrolateral (vl), ventromedial (vm), and dorsomedial (dm) prefrontal cortex (PFC); and
modulate early neural activity within the AVS, as evidenced by greater magnitude of event-related potentials
(ERPs) (i.e., N1, P1, and LPP). The vlPFC and vmPFC and their connections to the amygdala, facilitated by the
uncinate fasciculi (UF) white matter tracts, play a central role in emotional interference resistance. What remains
unclear is how development of AVS regions as well as the structural and functional connectivity within the AVS
promotes emotional interference resistance and contributes to trajectories of psychopathology common to
internalizing and externalizing disorders. We address these questions through the following Aims: 1) characterize
the neurodevelopment of emotional interference resistance in adolescence through adulthood; 2) characterize
the neurodevelopment of the temporal dynamics of neural activity during processing of emotional distracters; 3)
examine how deviations in neurodevelopment of emotional interference resistance create a vulnerability to life
stress to predict increasing trajectories of internalizing/externalizing symptoms; and (4) characterize
relationships among developmental changes in multimodal neuroimaging indices and trajectories of
internalizing/externalizing symptoms. We will recruit a sample of 210 10-25 year-olds (78% White, 13% Black,
4% Asian, 2% Latinx, 3% Multiracial) in an accelerated longitudinal design, with 30 participants (50%M/F, 2/3
at high risk based on parental diagnosis of an internalizing and/or externalizing disorder and elevated current
internalizing and/or externalizing symptoms) in each age range (10-11, 12-13, 14-15, 16-17, 18-19, 20-22, and 23-
25) followed longitudinally every 9 months to provide five assessments of internalizing and/or externalizing
symptoms, and every 18 months to provide three neural assessments. We will use multimodal neuroimaging to
investigate the neurodevelopment of resisting emotional interference using an emotional delay working memory
task. Findings will clarify neurodevelopment of emotional interference resistance and inform targeted early
intervention strategies designed to maximally strengthen the identified neural networks.

Public health relevance
PROJECT NARRATIVE Results from this study will help identify markers of vulnerability to psychopathology during early adolescence and early adulthood by investigating the neurodevelopmental mechanisms supporting the ability to modulate attention toward or away from emotional information in the context of goal-directed behavior, which is integral to emotion regulation. This information is lacking and critical for characterizing neurodevelopmental pathways of risk for internalizing and externalizing disorders. Additionally, the study will provide rigorous longitudinal data on the neurodevelopment of the ability to resist interference from emotional distracters contributing to the discovery of critical windows of brain plasticity when early interventions designed to strengthen neural networks supporting emotional interference resistance could be most effective in promoting emotion regulation.